EXERCISE OPTION PERIOD 1

The Contractor shall provide a centralized, web-based, information technology (IT) database that will provide user-friendly interfaces for entering, uploading/importing,
searching, downloading/exporting, and visualizing chemical structures and bioactivity, pharmacology, and toxicology data, as well as software technical support. The centralized data system will collect and maintain data which includes, but is not limited to, information on the chemical analogs produced by NIH-funded contractors and PIs (including chemical structures) and data from bioactivity, pharmacology, and toxicology assays. The data will be reviewed and analyzed by members of an LDT, PIs, CROs, NIH-hired consultants, and NIH staff.

Public health relevance
Information Technology support for development of treatments for neurological disorders. Storage of data and reports for the development of investigational new drug (IND) packages.